Implementing pathways to identify and address employment concerns among people with cancer across diverse clinical settings

PROJECT SUMMARY/ABSTRACT
Cancer diagnosis and treatment can lead to loss or reduction of employment with resulting losses of income,
health insurance, and quality of life. These employment changes exacerbate the financial strain that people
with cancer often experience. The overall objective of this project is to identify and refer patients with
employment concerns to existing employment support resources through implementation and evaluation of an
adaptive screening and referral workflow in diverse cancer care settings. Dr. Forcino will conduct a patient-
level needs and assets assessment (Aim 1), evaluate implementation determinants at the clinic level (Aim 2),
and design and pilot test an adaptive clinical workflow for screening and referral (Aim 3). These activities
support NCI's stated goals of improving employment outcomes among cancer survivors, facilitating systematic
financial hardship screening, and implementing health care delivery interventions that provide psychosocial
support. Dr. Forcino is a newly-appointed Assistant Professor in the University of Kansas School of Medicine's
Department of Population Health. To supplement Dr. Forcino's experience in patient-reported outcome
measurement, interventions focused on literacy-based disparities, conducting key informant interviews, and
research project management, she will pursue 4 training objectives. These include: (1) Developing
methodological skills to conduct rigorous implementation research, including implementation science and
pragmatic clinical trials; (2) Understanding social determinants and their interactions with health and social
care delivery systems; (3) Learning the principles of participatory research and applying them to the proposed
research program; and (4) Learning key professional skills to successfully lead an interdisciplinary research
team. Dr. Forcino will be mentored throughout the award period by Dr. Simon Lee (primary mentor, University
of Kansas School of Medicine), Dr. Ronald Chen (co-mentor, University of Kansas School of Medicine), and
Dr. Kathleen Lyons (co-mentor, MGH Institute of Health Professions) to support her progression as a cancer
control scientist. Dr. Forcino's long-term objective as an independent investigator is to sustain a patient-
centered research program focused on implementing innovations to improve healthcare quality and patient
experience with a focus on social needs among people living with cancer.

Public health relevance
PROJECT NARRATIVE Up to 260,000 people in the US each year experience a reduction or loss of employment due to cancer, which diminishes quality of life and limits healthcare access. Financial challenges resulting from these employment changes, like reduced income and loss of employer health insurance, lead to missed or inconsistent oncology appointments, chemotherapy, and oral maintenance therapies – which are associated with disease progression, cancer recurrence, and mortality. With this career development award, I will use my skills and training to identify patients at risk of employment reduction or loss and connect them to supportive resources, thus improving both employment and health outcomes and reducing disability.